Epitope-Paratope Characteristics and IgG1 Allostery in Fc-mediated Effector Function

Project Summary
This project seeks to enhance our understanding of the mechanisms underpinning Fc-mediated effector
functions in the context of infectious diseases. Despite the role of Fc-mediated effector functions in bridging
adaptive and innate immunity to combat various pathogens, certain infectious agents have evolved to evade
these immune responses, potentially exacerbating disease progression. To counter this, our research aims to
dissect the intricacies of Fc-mediated effector functions specifically targeting a viral surface protein. Our proposal
sets forth a comprehensive analysis of the factors influencing Fc-mediated effector mechanisms for a viral
surface protein by leveraging our novel assays for Fc-mediated effector functions. This assay has been
instrumental in establishing a correlation between immune protection in a number of immunization and antibody
therapy studies. Through a detailed exploration of how antibodies that recognize this viral protein enhance Fc-
mediated effector functions, we aim to elucidate the structural and functional parameters that can be “tuned” to
develop new antibody-based preventions and therapies. Further, this project will provide new insights on how
the human immune system protects against infections as well as maintaining immune balance to prevent
autoimmune diseases.
.

Public health relevance
Project Narrative Understanding the mechanisms of Fc-mediated effector function is key to understanding how antibodies protect against foreign insults to the body including, viruses, bacteria, parasites, fungi, and toxins. It is also key to understanding how the immune system remains balanced and how it can be engaged to mitigate somatic diseases by using prophylactic and therapeutic monoclonal antibodies. The principal goal of this proposal is to shed new light on the mechanisms of Fc-mediated effector functions in people.